Elucidating transmission of plasmids harboring blaKPC among carbapenem-resistant Enterobacteriaceae using long-range sequencing

PROJECT SUMMARY/ABSTRACT:
Rationale: Resistance to broad-spectrum carbapenem antibiotics has spread rapidly among
Enterobacteriaceae since the early 1990s, posing an escalating threat to medical care. While Klebsiella
pneumoniae comprise the majority of CRE in the United States, recent evidence suggests that CRE are rapidly
diversifying. This reflects the ability of carbapenem resistance genes to spread to between different strains of
Enterobacteriaceae via mobile genetic elements, particularly plasmids. Despite their important infection control
implications, the mechanisms by which these plasmids spread have not been fully elucidated. Candidate: As
an infectious diseases clinician with a masters’ degree in biostatistics, Dr. Angela Gomez-Simmonds’ previous
publications characterize the clinical and molecular epidemiology of CRE. Formal training in advanced
bioinformatics and genomic epidemiology will be critical for the completion of the proposed research and the
advancement of her career. With primary mentor Dr. Anne-Catrin Uhlemann, she has assembled a
multidisciplinary advisory team of experts to guide her training and research progress. Dr. Gomez-Simmonds’
long-term goal is to become an NIH-funded independent researcher using next-generation sequencing to
understand links between the bacterial evolution, resistance mechanisms, and clinical epidemiology of
multidrug-resistant Gram-negative nosocomial pathogens. Environment: The Uhlemann laboratory at
Columbia University Medical Center (CUMC) has the microbiology and sequencing tools necessary to carry
out the proposed research, as well as a large retrospective collection of CRE clinical isolates from diverse sites
to perform genomic studies. CUMC has a strong track record of supporting the career development of young
physician-scientists. Approach: We hypothesize that horizontal transfer of plasmids encoding blaKPC, the
dominant carbapenem resistance gene in the United States, is an important contributor to the spread of CRE
within hospitals. To overcome limitations in previous genomics studies using traditional sequencing platforms
such as Illumina, we will perform long-range plasmid sequencing. Plasmid-mediated transmission of blaKPC will
be characterized through three aims. In Aim 1 we will systematically assess the contribution of horizontal
transfer to the spread of CRE in a large retrospective collection of CRE isolates collected between 2009-2016.
In Aim 2 we will perform a case-control-control study to assess unique clinical risk factors associated with
horizontal transfer versus clonal spread; a third control group will consist of CRE-negative patients. In Aim 3
we will determine whether hospital environmental surfaces such as sink drains are reservoirs for blaKPC-
harboring plasmids. Phylogenetic analyses will be used to assess links between plasmid sequences from
clinical and environmental CRE and published genomes. In addition to elucidating the role of plasmids in the
diversification and spread of CRE, this research may contribute to the integration of long-range sequencing in
effective infection surveillance and control protocols to account for plasmid-mediation CRE transmission.

Public health relevance
PROJECT NARRATIVE: Carbapenem-resistant Enterobacteriaceae (CRE) pose an escalating antibiotic-resistant threat to public health and appear to be diversifying. The proposed research will examine transmission of carbapenem resistance genes between different species of Enterobacteriaceae via mobile plasmids using state-of-the-art long-range sequencing technology in order to 1) systematically assess the incidence of plasmid transmission in a CRE- endemic hospital and identify “hypertransmissible” plasmids contributing to CRE diversification; 2) assess specific clinical factors contributing to CRE colonization or infection following horizontal transfer; and 3) use phylogenetic analyses to determine whether hospital environmental surfaces are reservoirs for plasmids encoding carbapenem resistance genes, potentiating their persistence and spread. If successful, this study will clearly demonstrate the important contribution of plasmids to the dissemination of CRE, identify targets for enhanced surveillance, and validate the integration of long-range plasmid into effective CRE surveillance approaches accounting for the plasmid-mediated spread of CRE.